Development of an Ultrasensitive Blood-based Diagnostic for Alzheimer's Disease

Project Summary: Alzheimer's disease (AD), prevalent among the elderly, is a fatal neurodegenerative
disorder marked by memory deficits and cognitive decline. It currently afflicts approximately 6.5 million
Americans with an estimated 500,000 new cases diagnosed annually. One challenge in improving AD
treatment is delayed intervention, as AD develops years before symptoms are evident. Objective, accurate
diagnosis of AD is critical for effective intervention but remains an unmet clinical need. Existing diagnoses
involve either lengthy and subjective clinical tests with neuroimaging or expensive and invasive procedures like
lumbar punctures. This work aims to engineer an ultrasensitive blood-based diagnostic tool that can
accurately determine the presence and severity of AD, to inform effective treatment. The accuracy of blood
tests is partly hampered by scarce presence of neurological proteins, as the blood-brain barrier (BBB) restricts
their presence. Blood extracellular vesicles (EVs) can reflect protein profiles in inaccessible brains, as they can
traverse the BBB. Utilizing markers in EVs improves accuracy and reliability of current blood tests. Yet,
developing cost-effective, streamlined, and scalable EV isolation tools remains a challenge. Integrating
analysis of novel and robust AD biomarkers in EVs may further enhance AD diagnosis. One such marker could
be the collective phosphorylation changes in tau, as an increase in tau phosphorylation correlates with tau
aggregation. However, a highly selective and quantitative assessment of protein phosphorylation is lacking.
The diagnostic challenge lies in the low concentrations of AD-specific biomarkers present in EVs, particularly
the minute fraction of phosphorylated proteins. Therefore, the proposed diagnostic tool will utilize single
molecule detection to measure low abundance AD protein biomarkers in EVs. Single Molecule Array
(Simoa) technology, developed by the Walt lab, is the current state of the art for ultrasensitive protein
detection, using digital enzyme-linked immunosorbent assay (ELISA) to isolate and count single molecules in
femtoliter-sized microwells, achieving 1000-fold higher sensitivity than conventional ELISA. An integrated
pipeline designed to efficiently isolate EVs from plasma and quantitatively uncover the phosphorylation state of
AD diagnostic biomarkers is required to advance AD diagnosis. This pipeline can be achieved through
multiplexed Simoa assays developed for a panel of robust AD protein biomarkers, enabling a simple, accurate,
minimally invasive, and cost-effective diagnostic tool for AD, using plasma EVs. This project will provide Dr.
Stephanie Zhang rigorous scientific training for an independent academic research career. She will work
closely with Dr. David Walt in a highly interdisciplinary, collaborative environment at Brigham and Women’s
Hospital and the Wyss Institute, and develop an extensive skillset in analytical chemistry, diagnostics, and
technology development and translation. The training plan also provides opportunities to expand her scientific
expertise and professional skills through coursework, seminars, conferences, and grant writing workshops.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a leading cause of death and an increasingly urgent health concern, as it afflicts a growing percentage of the elderly population, with observed disparities across racial and educational demographics. Objective, accurate, and reliable diagnosis of AD remains a severe unmet need, as existing diagnoses involve either lengthy and subjective clinical tests with brain scans or expensive and invasive procedures like spinal taps. To address this challenge, the proposed research aims to develop an ultrasensitive, cost-effective, and minimally invasive diagnostic tool for accurately measuring a panel of novel and robust AD protein biomarkers in blood, to inform effective intervention.